Administrative Core

The wealth of new discoveries in the field of primary immunodeficiencies published in the last few years, combined with our own findings, has galvanized this team of experienced researchers. The two clinicianscientists (Raif Geha and Luigi Notarangelo) together with the two molecular biologists (Fred Alt and Cox Terhorst), propose to integrate their considerable expertise into a new Program Project Grant application entitled: